Personalized Model System Core

PROJECT SUMMARY:
A key component of this P30 application is the ‘Personalized Model System Core’. The models will
include the patient-specific cultures derived from intestinal epithelia (enteroids) and the induced pluripotent
stem cells (iPSCs) from myofibroblasts. These patient specific cultures will be used to study CFTR function
and fluid homeostasis, and the information obtained will be used towards personalized treatment options.
The Personalized Model System core will develop and bank these models, develop and validate the assays
for CF/CFTR research, and distribute the resources to researchers worldwide. The long-term goal of this
core is to use models derived from the patient to facilitate his/her personalized therapy. Specific Aim 1.
Will be to provide CF patient-specific enteroids (small bowel and colonic). Specific Aim 2. Will be to
provide well-characterized CF patient-specific induced pluripotent stem cells (iPSCs)-derived tissue from
myofibroblasts. Specific Aim 3. Will provide assay services and training to local, national and international
investigators interested in personalized model system to study the functional involvement of CFTR fluid
secretion in intestinal enteroids, spheroids and organoids.
The Core will create resources and sound services that have important long term clinical
implications toward patient-specific therapies for cystic fibrosis. The core will provide training in a variety of
state-of-art and innovative techniques including the development of intestinal stem cells cultures, iPSCs
technology, high content microscopy, to name a few, to researchers who will be able to use these
techniques to study not only CF/CFTR biology but other membrane proteins and their associated diseases.